VARIATIONS IN XENOBIOTIC METABOLISM DURING THE MENSTRUAL CYCLE

This study intends to examine how levels of certain metabolizing enzymes may vary in the body, depending upon hormonal variations during the menstrual cycle.